Southern HIV and Alcohol Research Consortium Biomedical Data Repository

Abstract:
The number of persons living with HIV (PLWH) continues to increase in the United States.
Alcohol consumption is a significant barrier to both achieving the goal of ending the HIV
epidemic and preventing comorbidities among PLWH, as it contributes to both HIV transmission
and HIV-related complications. Recent advances in data capture systems such as mHealth
devices, medical imaging, and high-throughput biotechnologies make large/complex research
and clinical datasets available, including survey data, multi-omics data, electronic medical
records, and/or other sources of reliable information related to engagement in care. This offers
tremendous potential of applying “big” data to extract knowledge and insights regarding
fundamental physiology, understand the mechanisms by which the pathogenic effects of biotic
and abiotic factors are realized, and identify potential intervention targets. We propose to
integrate the disparate data sources maintained by our partners and then utilize the big data to
address research questions in treating HIV and alcohol-related morbidity and mortality.
Specifically, we will pursue the following three aims: 1) Integrate the disparate data sources
through standardization, harmonization, and merging; 2) Develop a web-based data sharing
platform including virtual data sharing communities, data privacy protection, streamlined data
approval and access, and tracking of ongoing research activities; 3) Provide statistical support
to junior investigators to use the data repository for exploratory data analysis and proposal
development. The proposed study will tap into disparate data sources, unleash the potential of
data and information, accelerate knowledge discovery, advance data-powered health, and
transform discovery to improve health outcomes for PLWH.

Public health relevance
Project Narrative We propose to integrate the disparate research data, and then utilize novel statistical and AI approaches to address research questions in treating HIV and alcohol-related morbidity and mortality. The proposed study will unleash the potential of data and information, accelerate knowledge discovery, advance data-powered health, and transform discovery to improve health outcomes for people living with HIV.